Preventing Substance Use Among Youth in Foster Care Through Collaborative Court Appointed Special Advocates(CASA) Brief Intervention

7. Project Summary/Abstract
Research documents that youth in foster care exhibit elevated risk for substance use problems compared to
the general adolescent population. Yet substance use prevention programs often fail to reach youth in foster
care due to a number of factors, including high rates of placement instability, a critical lack of substance use
programming tailored for the unique needs of youth in foster care, and implementation challenges. Increasing
referrals is not an effective strategy alone, and substance use prevention is not part of services as usual for
youth in foster care. The objective of this R01 is to leverage a robust existing service delivery program for
youth in foster care, Court Appointed Special Advocates (CASAs), to deliver an evidence-based intervention
(EBI) specifically focused on trauma-informed substance use prevention, called CASA Brief Intervention (CBI).
We will first adapt core components of existing EBIs so that they are tailored for the needs of youth in foster
care and can be delivered by CASAs (Aim 1). We will then conduct a large-scale hybrid type 1 effectiveness-
implementation randomized trial to test whether the adapted intervention improves substance use outcomes
for foster youth compared to CASA services-as-usual (Aim 2 and Aim 3). CASAs are ideal interventionists for
youth in foster care because the structure for hiring, training, and monitoring CASAs to support youth in foster
care already exists nationwide. In this proposal, we build on an existing partnership between the University of
Oregon, CASA of Lane County, and the joint CASA program of Josephine and Jackson Counties. The overall
goal of this project is to expand our current partnership with CASA to co-adapt and deliver effective substance
use programming to youth in foster care. Findings will clarify the implications of using a lay health worker model
to improve the implementation, sustainability, and scalability of substance use prevention programming for youth
in foster care. Given that CASA is currently in 49 U.S. states, serving approximately 242,000 (60%) youth in
foster care, the potential for scalability and reach is exceptional if the current project demonstrates that the EBI
delivered by CASAs effectively prevents substance use and improves outcomes for youth foster youth.

Public health relevance
8. Project Narrative Additional substance use prevention efforts are needed for youth in foster care because they are more likely to have experienced exposure to parental substance use and subsequently, have greater risk for substance use problems themselves. The proposed project will adapt and evaluate an evidence-based intervention focused on substance use prevention to be delivered to youth ages 11-14 in foster care through a novel service delivery mechanism, Court Appointed Special Advocates (CASA). Given that the infrastructure of CASA exists in 49 states and serves 60% of youth in foster care, the public health impact is high for potential scalability and sustainability of this novel strategy for preventing substance use among youth in foster care.